Concurrent Validity, Test-Retest Reliability, and Sensitivity to Change of Functional Near-Infrared Spectroscopy for Measuring Language-Related Brain Activity in Post-Stroke Aphasia

More than 2.5 million people in the U.S. have aphasia, a language disorder most often caused by stroke that
dramatically affects an individual’s functional independence and quality of life. For several decades, fMRI has
critically advanced aphasia research, but it has notable limitations. For example, individuals with conditions
that affect many Veterans (e.g., implanted medical devices or a history of injury involving metal) cannot safely
be scanned. These individuals have therefore been systematically excluded from fMRI studies of aphasia.
Additionally, fMRI is conducted in a noisy, restrictive environment, necessitating the use of artificial
experimental paradigms that may not engage the full range of anatomical and physiological mechanisms
supporting real-world language and communicative function. In contrast to fMRI, functional near-infrared
spectroscopy (fNIRS) has few contraindications, is silent, inexpensive, and can be administered in a standard
clinic room with naturalistic language paradigms. Despite these advantages, fNIRS has rarely been used to
study aphasia, likely due to a lack of data validating it as compared to fMRI in this specific population. This
study will address critical gaps in the evidence that would support fNIRS’ use by investigating its correlation
with fMRI for language mapping (Aim 1), its test-retest reliability (Aim 2), and its sensitivity to changes in
brain function due to behavioral language treatment (Aim 3) in people with chronic post-stroke aphasia.
In part A of this study, 24 people with chronic aphasia (PWA) will be scanned twice over a 3-week interval
with both fNIRS and fMRI while performing three language tasks: picture naming and semantic and
phonological matching. Concurrent validity will be established by correlating language activation measured by
fNIRS with that of fMRI. fNIRS’ test-retest reliability will be assessed by computing intraclass correlation
coefficients across the first and second fNIRS scans, with comparable comparisons of the fMRI scans. Twenty-
four healthy older adults will complete the same protocols to inform interpretations of the results in PWA. In
part B, 12 PWA will complete fNIRS and fMRI scans during language tasks before and after three weeks of
intensive language therapy, administered as part of a separate clinical trial of treatment for word-retrieval
impairments. Comparisons between pre- and post-treatment fNIRS and fMRI scans will be used to assess
fNIRS’ sensitivity to change after intervention, relative to that of fMRI. Behavioral research activities (including
intensive language therapy) will be conducted at the VA Pittsburgh Healthcare System (VAPHS). fMRI and
fNIRS will be performed at the CMU-Pitt Brain Imaging Data Generation & Education Center and the Brain
and Auditory Sciences Research Initiative at the University of Pittsburgh, respectively.
The results of this study will help determine the viability of fNIRS for measuring language functions in
post-stroke aphasia and may provide a foundation for increased use of fNIRS in aphasia research, broadening
participation in neuroimaging studies and increasing the generalizability of their findings. The results may also
support the development of novel uses for fNIRS, such as measuring brain responses during everyday language
use or aphasia treatment, and using real-time neurofeedback as an adjuvant to behavioral aphasia therapy.
The applicant is a VA CDA-1 awardee, research and clinical speech pathologist, and former Advanced
Geriatrics Fellow in the Geriatric Research, Education, and Clinical Center at VAPHS, with experience in
aphasia rehabilitation and fMRI. During the CDA-2, mentorship and structured training activities in advanced
neuroimaging/fNIRS methods, advanced statistics, Bayesian adaptive clinical trials design, and validity theory
will facilitate execution and completion of the project and achievement of the applicant’s career goals. These
goals include completing a CDA-2 and becoming an independent VA clinician-scientist supported by VA Merit
Review and NIH/NIDCD award mechanisms, with a research program focused on improving service delivery
and maximizing treatment outcomes for Veterans and others with aphasia.

Public health relevance
Aphasia is a debilitating and often chronic language disorder that has dramatic consequences for communication and quality of life. Aphasia affects more than 2.5 million Americans, including thousands of U.S. Veterans. Given evidence that stroke, the leading cause of aphasia, is more common in Veterans than non- Veterans, VA has a vested interest in developing and implementing novel prognostic and therapeutic tools for aphasia management. Research on the brain systems implicated in aphasia and its rehabilitation has relied heavily on fMRI, but fMRI has contraindications that are exclusionary for many people with aphasia. This project aims to validate functional near-infrared spectroscopy (fNIRS), a lower-cost, less-restrictive neuroimaging technology that could reduce barriers to the use of neuroimaging in research and clinical care for Veterans with aphasia. The project will help establish the viability of fNIRS for studying, predicting, and potentially accelerating or augmenting aphasia rehabilitation, laying the groundwork for future clinical trials.